Trajectories of Cannabis Use in Pregnancy

Cannabis use in pregnancy is becoming increasingly common despite recommendations from healthcare providers and
professional organizations for abstinence. Evidence exists that cannabis exposure in utero, particularly after the first
trimester, is associated with risks of adverse pregnancy outcomes and negative effects on the long-term
neurodevelopment of the exposed neonate. Despite this, approximately one in four pregnant women who uses cannabis
will continue to use throughout her pregnancy.
The data that exist currently suggest that continued use in pregnancy is associated with the highest risk of adverse
outcomes. However, most of our understanding of patterns of use come from cross-sectional surveys and consist only of
the binary outcomes of continuation or abstinence. There is a need for longitudinal data evaluating trajectories of
cannabis use during pregnancy, including changes such as decreases in use. Defining these trajectories will help to
further delineate if a dose-dependent relationship between exposure and outcomes exist. Equally as important,
understanding both baseline and time-varying factors that are associated with different cannabis use trajectories can be
used to inform counseling, support and treatment efforts with the ultimate goal of improving maternal and child health.
We plan to recruit 1,200 pregnant people who present for prenatal care at six different clinical sites across two
institutions in Maryland and California. The cohort will include 800 people who self-report cannabis use within the 30
days prior to pregnancy recognition and 400 who do not. We will collect baseline demographic information, health and
mental health history and detailed information on frequency, quantity and mode of cannabis use and other substances
prior to and since recognition of pregnancy. We will then follow these women throughout pregnancy with monthly,
electronic surveys using Timeline Followback to quantify use. In addition to self-report of use, we will use urine drug
testing for confirmation. Latent Variable Mixture Modeling will be used to define varying trajectories of cannabis use in
pregnancy. In order to evaluate both baseline and time-varying factors associated with differing trajectories of use, we
will also capture data on mental health status, pregnancy symptoms, motivations and intentions for use and social
determinants of health at enrollment and once per trimester throughout pregnancy. We will compare birth outcomes
between different cannabis use trajectories and those of women who do not use.
We intend to 1) define trajectories of cannabis use during pregnancy among women who used cannabis within the
month prior to pregnancy recognition 2) determine both baseline and time-varying factors associated with different
cannabis use trajectories 3) compare birth outcomes across cannabis use trajectories to those of pregnant people who
do not use cannabis.
The results of this study will aid in the development of more comprehensive approaches to cannabis use counseling and
treatment with the goal of improving maternal health and decreasing rates of substance exposed newborns.
Additionally, our results will inform future studies on the effects of in utero cannabis use exposure.

Public health relevance
Narrative The proposed project aims to more clearly define if and how women change their cannabis use after recognition of pregnancy by following women throughout their pregnancy and quantifying use each month. Additionally, we intend to identify potentially modifiable factors that are associated with continued cannabis use during pregnancy in order to improve counseling and treatment efforts with a goal of improving pregnancy outcomes. We will also compare birth outcomes between women who continue to use, quit using or never used cannabis during pregnancy.